Cancer Cell-Extrinsic and Intrinsic Regulators of Tumorigenesis

PROJECT SUMMARY/ABSTRACT
Cutaneous squamous cell carcinoma (cSCC) is the second most common cancer overall in the U.S. and
causes substantial morbidity, with a significant risk of metastatic spread and death. Treatment options are limited
in unresectable cases, which are estimated at up to 40,000 per year. Advances in treatment have been hindered
by incomplete knowledge of intratumoral heterogeneity (ITH) in cSCC, particularly regarding how different tumor
subpopulations behave within a growing tumor. ITH can be driven by cell-intrinsic abnormalities within cancer
cells, but increasing evidence suggests that cancer cells communicate with diverse cell types, such as immune
or stromal cells, in the tumor microenvironment (TME) to coordinate malignant behavior such as invasion. Thus,
a deeper understanding of how ITH arises in cSCC, from both TME and cell-intrinsic contributions, has the
potential to yield new treatment strategies.
Recent discovery of a novel subpopulation of cSCC tumor cells was facilitated through single-cell profiling of
patient cSCC tumors. This tumor-specific keratinocyte (TSK) subpopulation was found to express a gene
signature that was absent in normal skin, suggestive of invasive capacity, and associated with worse prognosis
across several epithelial cancers. Spatial profiling demonstrated that TSKs resided at the tumor leading edge
adjacent to cancer-associated fibroblasts (CAFs), suggesting that crosstalk among these cell types in the TME
may control TSK cell state or function. Global ligand-receptor analyses integrating single-cell and spatial data
nominated specific CAF-derived ligands matched with receptors expressed by TSKs, including several integrins.
Integrin signaling genes mediating TME signals were required for tumor growth in CRISPR screens in vivo,
including ITGB1, FERMT1, CD151, and ARPC2. Thus, these data support a model in which signals derived from
TME cells proximal to TSKs promote tumorigenesis and potential invasion through ITGB1-mediated signaling.
Through two specific aims, this work will determine if blocking cSCC-specific CAF-derived factors and
disabling cancer subpopulation-intrinsic factors can impede TSK formation and subsequent tumor invasion and
progression in preclinical models. Aim I will employ a human organoid model of cSCC to assess the contribution
of CAF-derived ligands toward emergence of TSKs and invasion through genetic ablation and therapeutic
blockade. Aim II will determine how TSK subpopulation-specific factors cooperate to facilitate invasion in
organoids and tumorigenesis in xenograft mouse models through genetic manipulation of cancer cells to prevent
factor interaction. This work will be performed under the mentorship of Dr. Paul Khavari, a physician-scientist
and expert in skin cancer genetics, at Stanford University, a world-class research institution. These studies could
aid the development of novel therapeutic strategies to treat unresectable cSCC and lead to a deeper molecular
understanding of pathways enabling tumor invasion, heterogeneity, and progression.

Public health relevance
PROJECT NARRATIVE Cutaneous squamous cell carcinoma (cSCC) is the second most common cancer overall in the United States, of which a substantial number of cases are unresectable and lack treatment options. Therapeutic strategies are limited in part due to poor understanding of how intratumoral heterogeneity (ITH) arises and triggers invasive behavior in cSCC, but recent work suggests that factors from the tumor microenvironment (TME) and cancer cell-intrinsic factors both contribute to ITH. This work aims to identify specific crosstalk pathways between the tumor and TME that lead to invasion and tumor progression to aid in developing therapeutic strategies to disable these processes.